Bridging Disparate Structural/Functional Scales: Multiscale Modeling of Genome Organization and if Viral RNA Frameshifting

Bridging Disparate Structural/Functional Scales: Multiscale Modeling of Genome
Organization and of Viral RNA Frameshifting
Project Summary May 22, 2024
As advances in both experimental and computational biology lead to exciting discoveries in many ﬁelds
of biology and biomedicine today, new avenues to diagnose and treat human disease are becoming a reality.
Molecular dynamics and other simulation approaches play a key role in these connections by helping deﬁne
the underlying biophysical mechanisms, at unprecedented resolution. The PI's computational biophysics lab
focuses on solving fundamental structural and functional challenges concerning nucleic acids and their complexes
(notably chromatin and RNA), in collaboration with experimentalists, by innovative molecular models and
simulation methods using ideas from mathematics, computer science, engineering, biology, and chemistry. This
MIRA project continues to advance our fundamental understanding of genome organization and RNA motifs
using multiscale models that bridge disparate spatial and temporal scales to generate biophysical insights into
genome folding and cancer genomics, and RNA conformational landscapes/ viral mechanisms. For chromatin and
chromosomes, modeled nucleosomes and their protein complexes at atomic resolution, and chromatin ﬁbers at the
mesoscale, will be linked to data from genome-wide and cancer epigenomics studies to determine the modulation
of chromatin higher-order structure in processes of aberrant gene expression. Speciﬁcally, we will focus on
the structural role and mechanisms of proteins (like CTCF and H1) in formation of gene loops, topologically
associated domains (TADs), and nuclear compartments in gene activation or repression in cancer cells. For RNA,
atomic-level biophysical modeling will be complemented by our topological coarse-grained graph approach for RNA
secondary structures (RAG: RNA-As-Graphs) to delineate programmed ribosomal frameshifting mechanisms in
RNA coronaviruses and other viruses, and advance the RNA motif atlas. Speciﬁcally, atomistic dynamics of
the RNA frameshifting element of SARS-CoV-2, along with evolutionary and biophysical analysis and chemical
reactivity experiments tailored to handle multiple RNA conformations will describe frameshifting transitions and
identify/test experimentally structure-altering mutations that hamper frameshifting. We will also build a virus
topology atlas and explore virus motifs from an RNA repertoire point of view, to help understand the RNA motif
universe and advance novel RNA design. The unraveled biophysical mechanisms in genome organization and RNA
frameshifting/conformational repertoire have translational ramiﬁcations for human cancers and viral infections by
coronaviruses or HIV. For cancer therapy, a targeted re-expression of silenced genes may be possible by chromatin
topological changes (e.g., loop dissolution) and RNA editing. For viral RNA infections, our structure-altering
and motion-suppressing mutants deﬁne new strategies for gene and anti-viral therapy, feasible by modern RNA
editing technologies. The resulting multidisciplinary computational paradigms are widely applicable to other
biomolecular processes and will be shared with the community at large.

Public health relevance
Project Narrative Using new multiscale biomolecular modeling and simulation methods that can yield mechanistic insights, Schlick's multidisciplinary team will address fundamental challenges in biology in relation to human disease: genome reorganization in cancer processes and RNA co-transcriptional folding in viral mechanisms. A linking of the many relevant biological scales and heterogeneous features of each is essential for understanding the complex biological activities of these macromolecules in the cellular environment and how they aﬀect gene expression, cancer progression, and viral infection. Such an improved understanding of the organization and transition mechanisms associated with the genetic material and its RNA cousin, together with establishment of systematic methods for the study of their heterogeneous conformational landscapes, has direct medical ramiﬁcations by suggesting speciﬁc molecular design and targeted therapies for the treatment of genetic syndromes, degenerative diseases, cancers associated with chromosomal or epigenetic abnormalities, and viral infections like Covid-19. Speciﬁc Aims Through this NIGMS Administrative Supplement, the PI seeks to obtain a dedicated 10-GPU (Graphics Processing Units) computing cluster for the Schlick lab to enhance, facilitate, and greatly accelerate the lab's computations and simulations of gene, RNA, and related systems to address fundamental biological challenges in new ways. The parent grant has speciﬁc aims related to elucidating structure/function relationships in genome and RNA systems by novel multiscale techniques. The currently available system at NYU is a large cluster with limited GPU access that is shared by four thousand researchers. While access was easier when the system was ﬁrst installed, large bottlenecks are now associated with thousands of eager users that result in large queue times and cancelled or interrupted jobs. Having the dedicated GPU system will enhance our productivity enormously and allow easy development and testing of new GPU-tailored algorithms for multiscale modeling of nucleic-acid systems of great importance to basic science and human medicine. Because researcher salary was priority for the PI in the MIRA budget, very modest equipment budgets were requested in both the original MIRA and renewal MIRA proposals. This request represents the ﬁrst major instrumentation request for the Schlick lab for the NIGMS MIRA project. Introduction to Application RE: Administrative Supplement for Equipment Purchases for Select NIGMS-Funded Awards for 2R35GM122562-06: NOT-GM-24-021 I am requesting an Administrative Supplement to purchase a 10-GPU (Graphics Processing Unit) computer system from Nvidia to be connected to the Schlick Lab Computer Cluster. This powerful system will provide our researchers direct and rapid access to computations and data storage that are not possible through the large NYU High-Performance Cluster serving thousands of other researchers, all competing for the same queues, especially for GPUs. This 10-GPU system will greatly facilitate, accelerate, and enhance computation and storage for our essential molecular modeling and simulations of genome systems at multiscale resolutions, RNA systems at the all-atom and coarse-grained levels, and related DNA/protein complexes at atomic resolution. The requested system has 10 Nvidia RTX 6000 Ada Graphics Processing Units, 256 AMD CPU cores, 5TB of memory, and 340 TB disk space. The quote from THINKMATE is $249,758.88 for this conﬁguration was solicited. This powerful GPU system will greatly enhance the productivity of our MIRA research projects and the group facilities. This system was not requested in the original submission because priority was placed on researcher salaries within the limited budget. The system will be maintained by Mr. Shereef Elmetwaly, the Chemistry Department's Scientiﬁc Computing Manager, whose oﬃce is in our lab space. Mr. Elmetwaly has maintained our computer systems for decades and is well experienced in the job and familiar with all researcher and their needs and many hardware and software systems for molecular simulations. Any supplies and warranty needs not covered in the original system will be covered by the parent grant.